Anaerobic Core Remodeling Project

PROJECT SUMMARY/ABSTRACT
This Phase I COBRE will create the Oklahoma Center for Microbiome Research (OCMR) to broadly address
key principles and questions concerning microbiome structure and function. The overarching goal is to create
the intellectual environment necessary to support five Research Project Leaders in Microbiome Science. Each
project involves studies of strict anaerobes. This Phase I COBRE will provide cutting-edge tools to cultivate
strict anaerobes by creating an Anaerobic Microbiology Research Core. Creating the Anaerobic Core will
require alteration and renovation of existing space to accommodate the necessary new equipment and
activities required to support the five Research Projects and the entire community of OSU microbiome
researchers.